A 400 MHz NMR Spectrometer

Project Summary
We are requesting funds to purchase a new Bruker Avance Neo 400 MHz spectrometer with
multinuclear capability. This instrument is intended to replace our two current general use 400
MHz spectrometers that are both aging and difficult/expensive to keep running, both being
Varian/Agilent instruments that are no longer supported. The Bruker Neo 400 will be used for
walk-up 1D 1H NMR, as well as 13C, 31P, 19F, 11B spectra, variable temperature and 2D
experiments. Currently, walk-up 400 MHz NMR is required for the research of 10 Brandeis PIs
in Chemistry, Biochemistry and Biology, comprising 6 Major and 4 Minor users who are
supported by eight R01 or R35 (MIRA) grants, two R21s and an R03, three NSF grants, one Air
Force grant and HHMI Investigator funding. A new, manufacturer-supported 400 MHz
spectrometer is crucial to ensuring the continued research progress of our NIH-funded
chemists, biochemists and biologists for the next decade.

Public health relevance
Project Narrative This is an application for funding to acquire a 400 MHz NMR spectrometer. This type of instrument is routinely used by anyone making novel small molecules, for instance, drug candidates, to make sure that the molecule they have made has the correct structure and is pure. This instrument will replace aging instruments used currently by 10 chemists, biologists and biochemists doing research primarily in biomedical projects.